Administration and Budgeting

The Administrative Core will provide centralized grant administration, communication processing, and budget management. This Core will also serve to amalgamate the investigators, their experimental findings and their ideas, evaluation of research efforts and direct the summary efforts toward the Program outcome. The Specific Aims of the Administrative Core are to: 1. Provide basic administrative services to the investigators. [unreadable] This includes the management of project supplies, filing, development of memos, meeting minutes and communications covering all operations, including publications. By design, this core will provide investigators with clear lines of scientific and administrative communication to promote collaboration among team members, aid in the prioritization of resources, and facilitate resolution of any problems that affect team members. 2. Organize monthly meetings of the Program Steering Committee. [unreadable] This Steering committee shall consist of the Project and Core Pis. 3. Organize a semiannual Internal Review Board meeting where a panel of experts shall assess the Program effectiveness and experimental progress, research directions, technical approaches, statistical evaluation, and administrative effectiveness. 4. Organize monthly Program Project Journal Club meetings for all members of the project and their laboratory members. 5. Organize an annual External Review Panel meeting. [unreadable] The members of External Review Panel shall review all experimental findings and clinical outcomes, help prioritize investigations, review the coordination of collaborations, and evaluate concepts that emerge from the studies. Provide publication services to the investigators for project-related communications where this includes the preparation of manuscripts, abstracts and other publications. Provide overall fiscal review, accounting, and real time budgets analyses. [unreadable] To conduct and direct the budget analysis including both descriptive summary expenditures and realtime tracking of individual budgets. [unreadable] Provide forward-looking projections on expenditures. These can be correlated with project progress to provide superior Program management. [unreadable] Provide timely review, quality assurance, and dissemination of the budgets in all projects.